Genomics Core Facility

PROJECT SUMMARY/ABSTRACT - GENOMICS CORE FACILITY (GCF)
The University of Chicago Medicine Comprehensive Cancer Center (UCCCC) Genomics Core Facility (GCF)
facilitate investigators’ genomic analysis by providing access to cutting-edge genomic methods and
technologies in a cost-effective manner for University of Chicago Medicine Comprehensive Cancer Center
(UCCCC) investigators. Understanding the genomic landscape of cancer and model systems is a critical
component of modern basic, translational, clinical, and population-based cancer research and a rapidly
evolving field.
In the current CCSG cycle (2018-2022), GCF supported 95 unique UCCCC members, with 227 federally
funded peer-reviewed grants and 200 peer reviewed publications (53% in journals with impact factor > 10).
The GCF leadership recognizes the value of developing, improving and evaluating new and existing
techniques, assays and/or reagents to ensure that UCCCC faculty have access to the latest genomics
capabilities. Consequently, the GCF has had rapid access to the latest available Illumina sequencer
(installed within one year of introduction by Illumina). Planned improvements for GCF are to 1) Implement
technology that will enable high-plex in situ analysis platform to provide spatial multiomics with formalin-
fixed paraffin-embedded (FFPE) and fresh frozen (FF) tissue samples at cellular and subcellular resolution;
and 2) Implementation of NovaSEQ-X (delivered March 2023) for higher throughput generation of very long
reads of sequence data per template and provides opportunity for genomic structural variant discovery.